Probing Heterogeneity of Alzheimer's disease using iPSCs

Alzheimer’s disease (AD) is a neurodegenerative disorder characterized by dysfunction and deterioration of
neurons resulting in loss of memory and progressive cognitive decline. Current treatments are aimed only at
symptom management. Three barriers to effective therapeutic development include: 1) a lack of definition of the
heterogeneity of AD pathogenesis, 2) a lack of highly predictive biomarkers to facilitate early intervention, and
3) a need to identify pathways involved in cognitive decline and AD that can be targeted for therapeutic
intervention. We are using induced pluripotent stem cell (iPSC) technology coupled to comprehensive studies of
patient populations to interrogate the cellular and molecular mechanisms underlying AD in an effort to break
down these barriers. We propose that there exist multiple forms of AD that have different underlying causes, and
that multiple therapeutic interventions may be needed to address disparate etiologies. Through other funding
sources, we have generated 50 iPSC lines from two cohorts, the Religious Order Study (ROS) and the Memory
and Aging Project (MAP). Here, we propose to study these lines, where we focus upon three categories of
subjects that lie on the extreme ends of the pathological spectrum: 1) no brain pathology, not cognitively
impaired, 2) high pathology not cognitively impaired, and 3) high pathology, late onset Alzheimer’s disease. In
addition, we have generated and/or collected iPSC lines from familial AD subjects, which will be analyzed in
parallel. Using iPSC derived neurons, astrocytes, and microglia from 60 human subjects, we will measure AD
relevant outcomes (Aβ, p-­tau, cytokines/chemokines) in Aim 1 and acquire unbiased transcriptomic and
proteomic data in Aim 2. These data will be integrated with clinical data, neuropathology data, and genetic data
acquired from the same subjects from whom the cells were derived using multiple computational approaches.
We hypothesize that: 1) Some pathological findings in the postmortem brain can be predicted by in vitro cellular
assays on iPSC derived neurons and glia (Aim 1), and 2) Both neuropathology and cognitive decline in some
human subjects can be predicted by transcriptomic and proteomic level network analyses of iPSC derived
neurons and glia. Preliminary data from 12 lines supports the premise that iPSC-­derived cells will capture certain
cell and molecular signatures that define subgroups of aged adults. Data from all 50 ROS/MAP lines and EOAD
models generated in aims 1 and 2 will provide a well-­defined framework to address mechanistic questions
regarding AD. In Aim 3 we will leverage the deeply characterized set of iPSC-­derived cultures to address the
hypothesis that dysregulated inositol 5-­phosphatase activity of INPP5D (SHIP1) and/or INPPL1 (SHIP2) leads
to an elevated risk for LOAD in a subset of subjects. Through these studies, we aim to evaluate whether iPSC-­
derived cells can act as a diagnostic or prognostic tool for cognitive decline and AD, and begin to address the
cell and molecular mechanisms underlying heterogeneity in LOAD.

Public health relevance
Clinicians and pathologists have long recognized that Alzheimer’s disease is heterogeneous in terms of age of onset, precise locations of pathology, co- morbid pathologies, and rate of cognitive decline. The overall goal of this study is to define subtypes of AD at a cellular and molecular level using stem cell- derived neurons and glia from carefully studied subjects. An effective method to subtype subjects would improve our sensitivity to 1) identify novel targets relevant to the underlying causes of disease, 2) develop accurate biomarkers for early intervention trials, and 3) better stratify subjects for clinical trials.